Depression And Primary-care Partnership for Effectiveness-implementation Research (DAPPER)

Project Abstract
Dominated by depression, mental disorders are a leading cause of global disability. Most of the disease
burden is in Low and Middle Income Countries (LMICs), where 75% of adults with mental disorders have no
service access. Despite nearly 15 years of efficacy studies showing that local non-specialists can provide
evidence-based care for depression in LMICs, few studies have advanced to implementation research. As
emphasized by a recent World Health Organization (WHO) initiative, integration of depression treatment into
existing systems of care is critical to achieving public health impact.
Our research team has worked in western Kenya for 5 years with a UCSF-Kenya collaboration that
supports integrated HIV services at over 70 primary healthcare facilities in Kisumu County (Family AIDS Care
and Education Services [FACES]). With high prevalence of Major Depressive Disorder (MDD) in Kenyan
primary care populations (26.3%, 3-5 times higher than in the U.S.), treatment for depression is a top concern
for Kenyan mental health leaders. Kenyan leaders recently launched a government-funded initiative to scale-
up treatment for mental disorders in primary healthcare, prioritizing depression. Yet, they lack an evidence
base for the two essential treatments –psychotherapy and second generation antidepressants—without which
Kenyan care scale-up will fall short of its potential. The proposed research responds to this need.
We propose to partner with local and national mental health stakeholders in Kenya to evaluate: (1) non-
specialist delivery of evidence-based depression treatment integrated within existing healthcare centers in
regards to clinical effectiveness and implementation parameters; including (2) costs and cost-benefit ratios for
depression care. Given that evidence-based psychotherapy and second-generation antidepressants are the
two leading first-line treatments for depression and are feasible to deliver in Kenya, our goal is to test an
implementation strategy for improving equitable access to these treatments by integrating them with primary
care. Our proposed study uses an effectiveness-implementation hybrid design type I to assess outcomes of
non-specialist delivered Interpersonal Psychotherapy (IPT) compared to fluoxetine, including assessment of
the service delivery mechanism.
Our approach differs from most prior work in our field because it uses an effectiveness-implementation
design, compares outcomes for IPT versus second generation antidepressant, integrates depression treatment
into primary care, and analyses depression care costs and cost-benefit ratios for each treatment arm. The
results of the proposed research will be significant in two ways: (1) they will produce a scalable strategy for
delivering depression treatments in sub-Saharan Africa using non-specialists integrated within existing primary
care structures and (2) they will produce a policy maker “menu” of short and long-term cost-benefit options for
integrated depression care with corresponding effectiveness and implementation values.

Public health relevance
Project Narrative Despite carrying the vast majority of the global mental disorder burden, 75% of adults with mental disorders in Low and Middle Income Countries have no access to services. This study will test strategies for integrating evidence-based depression treatments with primary care services at a large public sector hospital and conduct robust cost and cost-benefit analyses of each treatment to produce a “menu” of cost-benefit options for integrated depression care with corresponding effectiveness and implementation values. The project is relevant to the mission of the National Institutes of Mental Health because it addresses mental health care delivery and related health economics at the individual, clinical and systems levels.